PILOT TRIAL TO ASSESS IMMUNE STATUS IN CHILDREN WITH CHRONIC HEPATITIS B

The objective of this study is to improve the understanding of the underlying cellular mechanisms responsible for hepatitis B viral clearance in children with chronic hepatitis B.